Strategic Reprogramming of the Ergot Alkaloid Pathway

7. Project Summary
Ergot alkaloids improve human health as powerful and versatile pharmaceuticals for treatment of multiple
conditions including senile dementia, Alzheimer's disease, Parkinson's disease, migraines,
hyperprolactinemia, and type 2 diabetes. Tremendous diversity in structure and activity can be found
among the natural and semi-synthetic ergot alkaloids. Small changes in structure may lead to a great
changes in activity. The long-term goal of this research program is to understand and ultimately control the
biosynthesis of diverse ergot alkaloids by determining the functions of genes and gene products that
produce and diversify ergot alkaloids. One goal of this particular project is to understand and control the
biosynthesis of lysergic acid amides. Many of the more important pharmaceutical ergot alkaloids are
lysergic acid amides or could be derived from lysergic acid amides. The synthesis of these compounds
involves alternate and competitive mechanisms for off-loading amides from a non-ribosomal peptide
synthetase. An understanding of the genes involved in making these amide ergot alkaloids is now more
accessible because of their recent discovery in an experimentally tractable fungi, including three species
of Aspergillus as well as Metarhizium brunneum. A second goal of this project is to test investigate
recently discovered genes hypothesized to control regulation and secretion of lysergic acid amides; both
of these processes have translational significance. Specific aims of the proposed project are to: 1)
Understand and control competing non-ribosomal peptide synthetase offloading mechanisms for lysergic
acid amides; and, 2) Determine roles of novel ergot alkaloid synthesis genes in accumulation and
secretion of lysergic acid amides. Aim 1 will be pursued through two reciprocal but independent
approaches with alternate schemes for producing mutants of the reductase domain of a lysergyl peptide
synthetase to pair with other ergot alkaloid synthesis genes to understand steps in liberating lysergic acid
amides. The experimental approach to Aim 2 will involve application of transformation and CRISPR/Cas9-
based technologies we have developed to assess functions of a transcriptional regulator and a major
facilitator family transporter. The fungal strains produced by these genetic manipulations will be analyzed
by molecular and biochemical methods to determine how expression or alteration of the candidate genes
has affected the fungus's ergot alkaloid profile. Results of the proposed project will reveal roles of specific
genes and provide strains of fungi that produce molecules with pharmaceutical significance. Additional
benefits include meaningful experiences for graduate and undergraduate students and further
development of platforms for modification and improvement of additional or novel ergot alkaloids.

Public health relevance
8. Project Narrative The proposed project will provide information on the roles of novel genes in the biosynthesis of ergot alkaloids that serve as the basis of pharmaceuticals used to treat dementia, Alzheimer's, Parkinson's, migraines, and type 2 diabetes. Strains of fungi that produce rare and important ergot alkaloids will be derived. The project will provide meaningful educational and training experiences for several undergraduate students and a graduate student and develop platforms for future improvement of pharmaceutically relevant ergot alkaloids.